Ultra High-Pressure Liquid Chromatography Quadrupole Time of Flight Mass Spectrometer with UV-vis and Fluorescence Detection

Project Summary/Abstract:
The Agilent 1290 Infinity Series II ultra-high-performance liquid chromatography (UHPLC)
system with spectroscopic detection capabilities is a cutting-edge analytical instrument
specifically designed to separate highly similar molecules in complex samples. Seamlessly
integrated with the state-of-the-art Agilent 6530 quadrupole time-of-flight (QTOF) mass
spectrometer capable of simultaneous identification of metabolically relevant molecules in
complex samples. Agilent’s Mass Hunter software integrated with this instrument enables the
identification of a large number of compounds in complex biological samples.
Access to the UHPLC-QTOF is essential to stimulate biomedical research and education at an
undergraduate institution located in Eastern Montana, with a particular focus on serving
underserved Native American populations. Access to a UHPLC-QTOF will enable investigations
into disease mechanisms, protein structure and function, drug discovery, biomarker
identification, and toxicological studies. By providing access to this instrument, MSUB can
attract additional talented biomedical researchers, create networking opportunities, and foster
collaborations between academia and industry; the availability of these cutting-edge instruments
elevates the institution's profile, establishing it as a center for pioneering research and
education, and attracting external funding and other resources to support its endeavors.
The long-term goals of this proposal look to stimulate biomedical research and education while
fostering scientific advancements at MSUB and addressing health disparities, especially among
underserved communities. Central to these objectives is access to the analytical technology
offered by this UHPLC-QTOF, which empowers researchers and students to explore the rich
biodiversity and unique healthcare challenges in eastern Montana and around the world. By
providing undergraduate students with hands-on experiences in advanced analytical
techniques, MSUB will stimulate biomedical research and cultivate critical thinking among the
next generation of researchers. Furthermore, the long-term vision includes fostering
interdisciplinary collaborations between talented researchers at MSUB to contribute to current
and future projects, while also facilitating partnerships with local healthcare providers,
neighboring tribal communities, and industry partners. Such collaborations drive interdisciplinary
research and innovation, ultimately working towards the development of novel solutions to
improve healthcare outcomes.

Public health relevance
Project Narrative: The biomedical research and practice fields are becoming increasingly reliant on the use of sophisticated analytical instrumentation, including UHPLC-QTOF (Ultra-High-Performance Liquid Chromatography-Quadrupole Time-of-Flight mass spectrometer). The high resolution and sensitivity of Agilent’s state-of-the-art 6530 QTOF MS integrated with Agilent’s equally advanced 1290 Infinity Series II UHPLC create a robust system capable of effective and precise analysis of complex biological samples, such as tissues, fluids or environmental samples, making identification of contaminants, toxins, or disease markers possible; high-resolution mass spectrometry continues to be a foundational approach to both small molecule and metabolic interaction identification in biomedical research. Knowing the fundamental operation and how to employ these sophisticated instruments in addressing biomedical-related concerns through monitoring, early detection, and accurate assessment of health risks, supporting public health initiatives and interventions.